CARES-REACH (Colorectal Cancer Awareness, Research, Education and Screening-Rural Expansion, Access and Capacity for Health)

ABSTRACT
Despite the Healthy People 2020 goal of 70.5%, colorectal cancer (CRC) screening rates in Federally Qualified
Health Centers (FQHCs) are about 40%. The proposed study seeks to address this disparity and accelerate
the adoption of effective cancer prevention and control screening practices to promote CRC screening.
Leveraging our established community-academic network, which emphasizes participatory approaches among
community, clinical, and academic stakeholders, we build on our extensive preparatory research that tested a
low-literacy educational intervention plus Fecal Immunochemical Test [FIT]), and which resulted in initial
screening rates of 80%. This work was primarily carried-out in urban-based settings. Prior research shows that
repeat FIT screening rates often drop significantly without intervention and that there are notable geographic-
related CRC disparities with higher mortality seen among individuals in rural areas. Additional research is
needed to address repeat screening and expand our reach to other at-risk and rural populations. Informed by
a community-based participatory research (CBPR) framework and enriched by implementation science
approaches, CARES-REACH features a stepped wedge design with extension for maintenance to support an
implementation strategy focused on multiple levels: organizational, provider, and patient level that entail
processes to boost initial and repeat screening among average risk and age-eligible adults. This multilevel
study entails implementation of a core set of evidence-based interventions (EBIs) that include: low literacy
patient education (English, Spanish, and Haitian Creole language); provider education, system-wide electronic
medical record (EMR) tools and prompts, and FIT distribution plus an organization-wide cancer control
champion who motivates providers, navigates patients, and monitors system-wide screening activities.
Specific aims are to: 1) implement an organization-wide multilevel CRC intervention using EBIs plus a cancer
control champion in FQHCs located in rural and urban Central and Southwest Florida; 2) explore whether
practice setting and population characteristics may differentially impact annual clinic CRC uniform Data system
(UDS) screening rates; and 3) conduct a comprehensive evaluation of the implementation process (facilitators
and impediments), resource requirements, and intermediate patient outcomes for the program in FQHC
organizations. The intervention will be rolled out in a stepwise-method across clinics: one group of clinics
receives early intervention roll-out and the other clinics are delayed to allow for rigorous comparison. The main
outcome is change in annual clinic CRC screening rates compared to CRC screening rates of the prior year for
each clinic as well as comparing screening rates among early roll-out clinics vs. delayed roll-out clinics.
Addressing implementation processes will guide and direct scale-up to other FQHCs and community health
systems.

Public health relevance
PROJECT NARRATIVE Colorectal cancer (CRC) is a common cause of cancer death in the U.S. Yet, screening rates are less than optimal in many Federally Qualified Health Centers, even with new tests that can be done easily at home, such as the fecal immunochemical test (FIT). This study seeks to speed up the adoption of effective cancer prevention and control screening practices by promoting CRC screening in community clinics (rural and urban) in Central and Southwest Florida with added attention on repeat screening. A number of strategies will be implemented including low-literacy patient education combined with FIT distribution plus a cancer control champion. Our goal is to change the annual CRC screening rates at the clinics.